Interdisciplinary Network on Rural Population Health and Aging

Project Summary
U.S. population aging is occurring more rapidly in rural than in urban areas, rural areas are home to
disproportionate shares of older and sicker people, and rural-urban and within-rural disparities in health and
mortality are growing. New approaches to researching rural health and aging are needed that recognize that
rural America is not monolithic, it contains both resilient and vulnerable places, and its problems are multilevel
and multidimensional. The Interdisciplinary Network on Rural Population Health and Aging (INRPHA) will forge
new collaborations between scientists who study health and aging with others who focus on spatial disparities
and rural well-being. We will bring together dynamic clusters of scientists and recruit emerging, established, and
underrepresented researchers from multiple institutions across the U.S. to catalyze a new generation of research
on rural U.S. population health and aging. We will leverage a well-established USDA-supported national
consortium of researchers (W4001) that has been at the forefront of providing timely and policy-relevant evidence
on demographic trends in rural America. In addition, health and aging researchers and the institutional assets
within the proposed Network’s four lead universities – Penn State, Syracuse Univ., Univ. of Mississippi, and Univ.
of Colorado, Boulder – constitute a pool of expertise poised to provide novel, interdisciplinary, and regionally-
attuned understandings of social and spatial determinants of rural population health, health disparities, and
aging. The project’s aims are to (1) develop an open and evolving network that draws participants from multiple
regions, institutions, disciplines, career stages, and underrepresented groups; (2) design activities to generate
innovative research by enhancing the collective capacity of Network members and supporting formative research
through pilot grants, working groups, annual meetings, and training materials; and (3) conduct novel research
to: a) understand the multilevel and multidimensional mechanisms driving rural-urban continuum and within-rural
disparities in health and aging, b) detail the impacts of aging trends on rural communities, c) analyze the
intersection of rural economic livelihoods, health, and aging, d) examine the impacts of physical and social
isolation on cognitive health (including Alzheimer’s disease) and healthy aging in rural areas, and e) understand
relationships between environmental hazards and climate change for rural older adults. We will also attend to
intersections between race, rurality, and health and aging outcomes and how these relationships vary across
regional, state, and local contexts. A final aim is to (4) disseminate data, analytic resources, and research findings
to academic, policy, and public audiences through research briefs, webinars, data archiving, and other
mechanisms. Through INRPHA’s activities, emphasis is placed on developing a sustainable foundation to
support continued innovative, publicly-accessible, and impactful research on rural population health and aging.

Public health relevance
Project Narrative U.S. population aging is occurring more rapidly in rural than in urban areas, rural areas are home to disproportionate shares of older and sicker people, and rural-urban and within-rural disparities in health and life expectancy are growing. Through multiple mechanisms (pilot grants, working groups, annual meetings, mentoring activities, methods training), the proposed Network will bring together scientists with expertise in various health and aging outcomes (e.g., Alzheimer’s disease, chronic diseases, behavioral health, mortality), social determinants of health, rural economies, population and environment, and policy, along with data and methods across multiple sources, levels, and dimensions of health and aging to study the multilevel and multidimensional exposures shaping and being shaped by health and aging trends among different rural populations and regions. The Network will disseminate findings to academic, policy, and public audiences through presentations, academic publications, public research briefs and webinars, and congressional briefings, and will develop and disseminate data and analytic resources and training materials to ensure sustained and powerful impact in the area of rural population health and aging.